Establishing Basic Science-Clinical Collaborations to Understand the Molecular Mechanisms of Heterotaxy

Congenital heart disease (CHD) is the most common birth defect that affects nearly 1 in 100
liveborn infants. Heterotaxy (HTX) is a severe form affecting 3-4% of CHD patients where left-
right (LR) asymmetry of internal organs is not established correctly. Epidemiological studies
suggest that genetics plays a significant role in CHD. Uncovering the genetic pathogenesis for
CHD is essential to provide a more accurate prognosis for CHD-related interventions, assess the
risk for neurodevelopmental delays, and counsel families about recurrence risks. However, infants
that undergo clinical genetic testing, known mutations and genes that cause CHD are identified
in <30% of cases. This issue is exacerbated in patients from racial or ethnic backgrounds that are
underrepresented in current genetic databases. The overarching GOAL of this proposal is to
address this barrier using a multidisciplinary collaboration between clinicians, bioinformaticians,
and basic scientists. Our research has the potential to significantly improve care and outcomes
for HTX patients.

Public health relevance
Project Narrative Heterotaxy (HTX) is a disorder of left-right (LR) patterning of the form and function of internal organs like heart, affecting 1 in 10,000 live births. We have established a collaboration between clinicians and basic scientists to recruit patients with HTX and identify candidate genes/variants using whole exome sequencing, followed by their experimental analysis to validate the genes as disease-causing and improve our understanding of the underlying disease mechanisms.